timsTOF Pro Mass Spectrometer

ABSTRACT Analysis of glycoproteins is a specialized field of protein mass spectrometry. Behavior of peptides differs substantially from the behavior of glycosylated peptides whose analysis requires adjusted analytical methods. Few laboratories provide services in glycoproteomics and glycoprotein characterization because of the need for adjustments of the analytical technics and data interpretation tools. Researchers at the Clinical and Translational Glycoscience Research Center (CTGRC) at Georgetown University have documented expertise in analytical glycoproteomics and the CTGRC serves as a major hub for glycoproteomics in the Washington DC area. Here we request funds for a timsTOF Pro mass spectrometer to enable glycoproteomic projects supported by the CTGRC. This mass spectrometer has an exceptional combination of trapped ion mobility with high speed and resolution QTOF mass analyzer. The newly optimized workflows for efficient separation and fragmentation of glycopeptides on the timsTOF Pro allow unprecedented sensitivity in the detection, resolution and quantification of glycopeptides. The support from NCRR will enable us to provide expert support, currently in high demand and short supply, to funded projects at Georgetown University, in the Washington DC area, and at the National level.

Public health relevance
Project Narrative Glycosylation of proteins is involved in every major human disease. Biomedical researchers have an unmet need for mass spectrometric analysis of glycoproteins, a specialized field of mass spectrometry performed by few laboratories. The timsTOF Pro mass spectrometer will allow us to offer our expertise in support of the biomedical research community’s projects.